BLR&D Research Career Scientist Award Application

Age-related macular degeneration (AMD) is a slowly progressing disease involving genetic abnormalities
and environmental insults. It is the leading cause of blindness for older Americans; and as the population
ages, the prevalence of AMD continues to grow. Treatments are available for choroidal neovascularization
(CNV); but those come with risks and only target a subpopulation of AMD patients. No treatment is available
for early AMD, whereas new treatments for geographic atrophy (GA; >85% of all cases), are limited in effi-
cacy and come with significant side effects. This makes it paramount to develop diagnostic tools and a
treatment for early disease intervention. My Two Merit awards study two aspects of AMD. The BX Award is
focused on understanding how cell-cell communication is contributing to the spreading of disease through-
out the posterior pole. Specifically, we ask how extracellular vesicles (EV), which are released from all cells
in the body, contribute to distributing damage signal throughout the eye. Concomitantly, we are asking
whether EV content could be used as biomarkers for disease. For the RX award, while mechanistic studies
have shown that inflammation and smoking are fundamental components of AMD, genetic studies have
demonstrated that polymorphisms in complement proteins each increase the risk for developing AMD. One
of the most detrimental mutations occurs in factor H (fH) an essential inhibitor in the complement alternative
pathway (AP), suggesting that inadequate control of complement-driven inflammation is a major AMD risk
factor. Following the many encouraging data in animal models and early phase clinical trials, approaches to
block complement factor C3 (activator in the common terminal pathway, integrating all 3 pathways of com-
plement activation, as well as complement factor C5 (activator in the terminal pathway) were recently FDA
approved. However, both treatments are limited in efficacy and come with significant side effects. What
these tow strategies have in common is that most of the drug is wasted on non-pathophysiologically im-
portant target molecules; i.e., most complement components in fluids or tissue are not engaged in comple-
ment activation and hence to reduce complement activation for example at the RPE, Bruch’s membrane
(BrM) or choriocapillaris (CC), the majority of a given complement component has to be permanently inhib-
ited to achieve the desired effect. In addition, complement components are made in the eye and systemical-
ly, and many complement components can penetrate BrM; hence an almost unlimited reservoir of comple-
ment proteins exists that needs to be controlled. Given these complications, we are building on our previous
data. We are proposing to utilize antibodies and nanobodies against activated C3 to document complement
activation in the eye as a diagnostic marker, as well as to document efficacy for target engagement for
treatments. Second, by utilizing an “addressable” inhibitor that target to sites of complement activation re-
gardless of the location (CR2-fH) delivered via gene therapy, we will follow up on our successful animal ex-
periments by examining efficacy in 2D and 3D cell-based models of AMD, utilizing genetically characterized
iPSC derived RPE and choroidal cells. Additional lab in the Rohrer lab not funded through VA is aiming to
characterize disease mechanisms in AMD, focusing on deterioration of the outer blood retinal barrier (NEI-
R01), as well as utilizing the CR2-fH strategy towards vision loss in traumatic brain injury (DoD EBrap Vi-
sion Research Program). Overall, our work is designed to develop therapeutics and diagnostics in age- and
injury-related vision loss towards clinical application, with the long-term goal of developing a treatment to
improve veteran care and quality of life.

Public health relevance
Age-related macular degeneration (AMD) is an age-related disease with genetic and environmental risk factors that is significantly affected by smoking. AMD has two outcomes, wet AMD or dry AMD; and while there are treatments for the former, none are available for the latter. Developing novel treatment strategies, is therefore essential to reduce the incidence and progression of AMD and improve quality of life for Veterans with AMD. The goal of our research is to study mechanisms underlying AMD in cell- and animal- based experiments and develop novel diagnostic and treatment strategies to reduce the damage produced by the disease or help repair the tissues affected. Our long-term goal is to translate our treatment strategies from animal models to our veterans, which makes this research highly relevant to the VA mission.